Multi-Institutional Training in Genetic/Genomic Approaches to Sleep Disorders

ABSTRACT
Sleep and circadian disorders have a major impact on public health. Almost all aspects of sleep and
circadian rhythm are heritable as are common sleep and circadian disorders. Thus, there is a major opportunity
to study the genetic basis of sleep/circadian rhythm and different sleep disorders. Genomic approaches,
including development of novel biomarkers, are another area of opportunity. While these major scientific
opportunities are available, we do not have the scientific workforce necessary to address them. To address this
need, a multi-institutional training grant has been established in genetic/genomics of sleep and circadian
disorders. It takes a national, rather than single institutional, perspective. The program is led by faculty at the
University of Pennsylvania, which has the most advanced infrastructure for research training. The sites that
fellows train at are Johns Hopkins University, University of Michigan and Stanford University. A
multidisciplinary, talented faculty has been recruited to provide training. This includes experts in different sleep
disorders, in human genetics, in genomic approaches, including RNA seq, and use of multiple model systems
such as zebrafish and mice. The latter allows trainees to evaluate the functional role of gene variants identified
in human studies. The program has coordinated events that all trainees attend. These include research work-
in-progress talks, a grant workshop and lectures on genetics/genomics of sleep and circadian disorders. The
program has recruited 8 outstanding MD and PhD postdoctoral trainees, four of whom have already submitted
career development grants. All individuals who have entered the program remain in biomedical research in
academic settings.

Public health relevance
LAY NARRATIVE Sleep and circadian disorders have a large impact on public health and lead to effects on all body systems—cardiovascular, metabolic and behavioral consequences of these disorders. Almost all aspects of sleep and circadian rhythm and sleep/circadian disorders are influenced by genetic factors. Currently, however, there is an insufficient scientific workforce to address this; hence this training grant takes a national approach and involves four leading institutions (University of Pennsylvania, Johns Hopkins University, University of Michigan and Stanford University).